Mechanisms and therapeutic potential of the autophagy-lysosome pathway in Alzheimer’s disease

Project Summary/Abstract
The overall objectives of this proposal are to elucidate novel mechanisms underlying the regulation of
the transcription Factor EB (TFEB) and autophagy-lysosomal pathway (ALP), and to investigate their therapeutic
potential as mechanism-based treatments for Alzheimer’s disease (AD). Genetic evidence indicates that
dysfunction of ALP contributes to the pathogenesis of AD. Furthermore, TFEB, a master regulator for lysosomal
and autophagic biogenesis, has been shown to mitigate AD progression in AD mouse models. Our preliminary
studies demonstrate that two protein phosphatases, CDC25A and PP2A, regulate TFEB signaling and
downstream ALP pathway and Tau clearance. Importantly, we found that inhibition of CDC25A activates TFEB
in an AMPK-mediated manner; that inhibition of lysosomal acidic ceramidase (ASAH1) enhances PP2A activity,
thus leading to TFEB activation; and that a combined inhibition of ASAH1 and CDC25A activates TFEB
synergistically. Therefore, we hypothesize that CDC25A and PP2A play important roles in the regulation of
endolysosomal and autophagic network via modulating TFEB, and that inhibition of CDC25A and ASAH1 can
promote the clearance of Tau aggregates for AD treatment. In this proposal, we will elucidate the mechanisms
underlying the regulation of TFEB and lysosomal autophagic function by CDC25A/AMPK and ASAH1/PP2A
signaling. We will also examine the role and therapeutic implication of targeting CDC25A/AMPK and
ASAH1/PP2A signaling axis in AD pathogenesis and treatment. Interdisciplinary techniques including chemical
biology, proteomics, genomics, iPSC-based neuron differentiation, and mouse modeling for AD pathogenesis
will be used for this mechanistic and preclinical investigation. Success of the proposed research will lead to an
in-depth mechanistic understanding of the regulation of TFEB and ALP and achieve the proof-of principle of
potential therapeutic strategies for AD treatment by targeting CDC25A and ASAH1, alone or in combination.
Further, beyond Tau pathology, this study can be expanded in the future to APP/Aβ pathology in AD.

Public health relevance
This project investigates the mechanisms underlying the regulation of transcription factor EB (TFEB) and autophagy-lysosomal pathways (ALP) by cell signaling network involving protein phosphatases CDC25A and PP2A. Since abnormal ALP signaling is linked with Alzheimer's disease (AD), success of the proposed research will not only lead to an in-depth mechanistic understanding of the regulation of TFEB and ALP, it will also achieve the proof of principle of potential novel therapeutic strategies for AD treatment by targeting regulatory components of the CDC25A/PP2A signaling axis.